A mobile application to offer upfront healthcare prices and automated medical billing for socioeconomically disadvantaged Americans

Project Summary/Abstract
This SBIR Phase I project will develop a novel healthcare cost estimator and billing management mobile
application to assist minority health and disparity populations in America find affordable healthcare and
accurately pay medical bills. America has the largest per capita health expenditure in the world, and Americans
bear the significant burden of this with medical debt reaching US $81 billion in 2016 [1][2]. Over a quarter of
Americans have challenges paying for medical care and this disproportionately impacts those minority health
and disparity populations, leading to disparities in access and ultimately health outcomes. For example,
Blacks/African Americans are 25% more likely to have challenges paying for medical care than the average
American, Hispanics/Latinos - 30% higher and socioeconomically disadvantaged populations - 60% higher for
those who earn less than $50,000 [3].
To make fully informed decisions about their healthcare and be protected from surprise billing, patients must
know the price and quality of a good or service in advance. Approximately 73% of inpatient care and 90% of
outpatient care with the highest-spending are offered by multiple providers through the market, meaning if
patients researched and compared these before making informed choices they could see significant savings
opportunities, with figures of up to 19% shown in literature [4]. However, the evidence for this is conflicting [5].
On January 1st 2021, hospital pricing data for services and procedures became available for the first time, and
while this data is accessible, powerful players in the healthcare market are incented to keep this commercially
sensitive data opaque to the public [4]. Access to intuitive tools that simplify the research and comparison
process would make the effort minimal and incentives high to find low-cost, high quality care. The ability to
save pricing information related to the providers and services a patient may need, and the out-of-pocket costs
they may incur will avoid surprise bills and allow for reconciliation when bills are received. This can help avoid
excessive charges and empowers patients to inquire about discrepancies.
The scope of science proposed in this SBIR project is to develop a novel cost estimator search tool fed by an
aggregated database of hospital pricing information combined with an automated billing reconciliation tool run
on a smart device or laptop for a dynamic, user friendly experience completely free to the public.
Digital products of this nature are available for businesses today and have been shown to improve employee
engagement with, and accessibility and affordability of, healthcare services. However, those unable to afford
medical care are 3.4 times more likely to be uninsured (28.9M Americans), and part of families with incomes
below 400% of the poverty level (24.5M Americans) [6]. These individuals often don’t have the support of
employer-sponsored insurance and benefits, further widening the inequalities across the population.
Approximately 70% of socioeconomically disadvantaged populations do, however, own a smart device [7]. The
mobile health, cost estimator and billing management application developed through this project will offer for
the first time a direct-to-consumer solution agnostic of employer and health insurer, dedicated to
socioeconomically disadvantaged populations and their needs.
The benefit of this pioneering work will be meaningful pricing information and billing tools becoming more
universally available, protecting patients, reducing the cost of care and ultimately bridging the gap in
accessibility and affordability of healthcare in America.
In Phase 1, we will evaluate the technical feasibility and validity of the mobile application. In subsequent
phases we will evaluate the usability and effectiveness through human subjects research, while building the
required partnerships and sales channels to develop a commercially viable product.

Public health relevance
Project Summary/Abstract This project has relevance to public health through its contribution to knowledge on the role of price transparency in improving access to affordable healthcare for socioeconomically disadvantaged populations. It will provide insight on how an automated billing reconciliation tool can generate savings or reduce the accrual of medical debt for patients, leading to increased engagement with healthcare service. It will also demonstrate how intuitive mobile applications can be used by underserved populations to break down barriers to accessing and affording healthcare.